Data Analysis Core

PROJECT SUMMARY – DATA ANALYSIS CORE
Reproducible and robust computational methods, coupled with rigorous statistical analyses, are critical for the
success of the Center. We will ensure a unified approach to data analysis, integration, and management that
leverages the existing infrastructure and the computational strengths of our investigators. Our data analysis
effort will be divided into four tiers, with increasing level of data integration as we move up the tiers. Members
of the Data Analysis Core (DAC) will be involved in all phases of project planning, from design to execution, to
ensure that the data flow between the DAC and the OSPs and between our Center and other HuBMAP tissue
mapping centers is well coordinated. Members of the DAC have extensive experience in algorithm
development, genomics and imaging data analyses, large-scale data management, and coordination of data
analytic efforts within multi-project centers. We propose the following five specific aims.1) To design and
implement a pipeline for tier-one analyses using both public and in-house software tools. The pipeline will
handle raw data generated using all assay types by the Center. 2) To develop and deploy computational
methods for tier-two analyses. These methods will be used for the discovery and taxonomy of different cell
types in the heart and inference of spatial distribution of cells and gene expression patterns in the heart. 3) To
develop and deploy computational methods for tier-three analyses. These methods will be used for the
discovery of transcriptional regulatory pathways contributing to spatial and temporal heterogeneity of the heart,
and signaling pathways mediating interactions between different cell types in heart tissue microenvironment. 4)
To construct integrated multidimensional heart atlases. Using cell-centric signatures and pathway models
generated in Aims 2 and 3 as anchors, we will aggregate genomic and imaging data and metadata collected
throughout the project. 5) To collaborate with the HuBMAP Integration, Visualization, and Integration
collaboratory (HIVE) and other research centers of the Human Biomolecular Atlas Program (HuBMAP). We will
contribute to benchmarking of software generated by HuBMAP investigators, development of common data
formats, and improvement of interoperability of software tools.